Developing a Behavioral Weight Loss Intervention for Emerging Adults Implemented within College Health Service Centers

PROJECT SUMMARY/ABSTRACT
Forty percent of emerging adults (age 18-25) have overweight or obesity, which is unlikely to remit and
has significant health consequences. However, emerging adults are underrepresented in traditional weight loss
programs, drop-out at high rates, and have blunted weight loss outcomes. One potential way to improve
participation is to offer BWLIs in college health service centers to reduce barriers to participation. Approximately
40% of emerging adults are enrolled in a postsecondary institution and college health centers are used widely
by students. Moreover, delivering an intervention with design features that are responsive to emerging adult
preferences and lifestyles may also improve intervention effectiveness and attractiveness. The “small change”
(SC) approach to weight loss addresses emerging adult barriers to engagement by focusing on reducing calories
through a few self-selected, specific changes to current obesogenic behaviors, requiring less time and effort than
traditional behavioral weight loss interventions (BWLI) and promoting autonomy and self-efficacy. The SC
approach has been used effectively for weight loss in other populations. The goal of this K23 is to develop
and refine a novel and effective BWLI based on a SC approach that is designed for emerging adults and
for implementation in college health centers, an accessible care setting. To achieve this research goal, I
will develop a prototype BWLI for emerging adult college students (BWLI-College) that will integrate 1) results
from qualitative interviews with college stakeholder groups regarding perceived barriers and facilitators of
implementation in health centers and 2) previous findings regarding emerging adult preferences for weight loss
interventions (Aim 1A & 1B). Next, I will iteratively adapt the BWLI-College prototype through 2-3 uncontrolled
pilot trials with feedback from emerging adult students with overweight/obesity (N=10/trial) to maximize feasibility,
acceptability, and weight loss (Aim 2). Finally, I will test BWLI-College against a one-session psychoeducational
control group in a small randomized-controlled pilot trial (N=60; Aim 3). This project will fill a critical need for an
evidence-based weight management intervention for emerging adults that can be delivered via college
campuses. To complete this K23 research study, I propose to receive training in 1) designing and testing obesity
interventions, 2) the unique features of emerging adult populations, 3) implementation principles and methods
for the translation of obesity interventions to real-world settings and 4) advanced statistical methods for
longitudinal data from efficacy and effectiveness trials. With this training and research plan, the comprehensive
team of mentors I have assembled to facilitate my progress, and the rigorous academic and training environment
of Brown University and The Miriam Hospital, I will be well-positioned to launch my career as an independent
investigator dedicated to developing, testing, and implementing novel obesity interventions to provide early
treatment of obesity and prevent the associated downstream health consequences in later adulthood.

Public health relevance
PROJECT NARRATIVE Forty percent of emerging adults have overweight or obesity; however, emerging adults are underrepresented in traditional weight loss programs, drop-out at high rates, and have blunted weight loss outcomes. In this project, I propose to develop, iteratively adapt, and pilot test a behavioral weight loss intervention designed specifically to optimize feasibility, acceptability, and weight loss in emerging adults as well as be easily disseminable and implementable in college health service settings to improve intervention reach and access. This project will address a critical public health need and explore a novel treatment delivery model to improve weight status in emerging adults in the present that could reduce increasing obesity and related downstream health consequences in later adulthood.